A Dynamic Diversity of Dopamine Neurons

We aim to understand the biophysical mechanisms that enable the distinct intrinsic dynamics of projection-
defined dopamine (DA) neuron subpopulations by a combination of modeling and in vivo/in vitro experimental
strategies. We focus on how intrinsic dynamics differ between defined DA subpopulations, and how those
differences shape the integration of synaptic input within the circuit, including newly identified modes of burst
generation in DA neurons in vivo: plateau bursting and rebound bursting. We contrast a compressed dynamic
firing range DA population (DACR) with an extended dynamic range (DAER) based upon the maximum
frequency exhibited in response to depolarization, thereby probing differences in suprathreshold dynamics. We
also contrast ramp rebound (DAramp) and burst rebound (DAburst) populations based on the qualitative differ-
ences in post- hyperpolarization responses, which probe subthreshold dynamics. These categories are asso-
ciated with distinct axonal projection targets, implying participation in different circuits. One focus is on the
contributions of NaV channel gating and KV7 channel function to the extended versus compressed dynamic
range phenotype. The other focus is on the contribution of CaV3, KV4 and HCN channels to the rebound
ramp versus rebound burst phenotype. In each case, we apply projection-specific molecular interventions and
record extracellularly from freely moving mice to probe the causal role of altered intrinsic dynamic signatures
for motivated behavior. Computational modeling of distinct subpopulations (Canavier lab) guides experiments
based on mathematical insights on how the dynamics of bursting and pacemaking emerge from the ensemble
of ion channels. Patch-clamping in vivo DA mouse neurons with defined projection targets and selective
genetic manipulation of subpopulations (Roeper lab) provides critical insights into how the activity of distinct
subpopulations relates to behavior. We will generate predictions with computational models of DA
neuronal subtypes and test via in vitro and in vivo electrophysiological experiments in a synergistic
loop to define the causal contributions of identified biophysical mechanisms to relevant firing patterns. In Aim
1, we test the hypothesis that lower availability of auxiliary NaV subunit FGF13 in DAER allows higher maximal
rates in vitro than in DACR, that DAER firing range is further extended by plateau bursts, and that high
frequency bursts increase motivation or learning rate in a DA subpopulation specific manner. In Aim 2, we test
the hypothesis that the interplay between CaV3 (but not HCN) and KV4 in the dendrites determines whether the
DAramp or DAburst phenotype is expressed, and that the homogeneous responses of the DACRburst in the dorso-
lateral striatum (DLS) facilitate synchronized rebound bursting responses to disinhibition that facilitate move-
ment initiation. A better understanding of the intrinsic properties of distinct subpopulations of dopamine neurons
will be invaluable in targeting therapies for disorders with abnormal dopamine signaling, such as substance
abuse disorders, Parkinson’s disease and schizophrenia.

Public health relevance
We aim to understand the biophysical mechanisms that enable the distinct intrinsic dynamics of dopamine (DA) neuron subpopulations that project to distinct targets by a combination of modeling and in vivo/in vitro experimental strategies. We focus on how intrinsic dynamics differ between defined DA subpopulations, and how those differences shape the integration of synaptic input within the circuit, including newly identified modes of burst generation in DA neurons in vivo: plateau bursting and rebound bursting. A better understanding of the intrinsic properties of distinct subpopulations of dopamine neurons will be invaluable in targeting therapies for disorders with abnormal dopamine signaling, such as substance abuse disorders, Parkinson’s disease and schizophrenia.